Mechanisms of DMP Development and Atrioventricular Septation

Valvuloseptal development involves a series of events during which septal structures and valves,
which together are responsible for the unidirectional flow of two blood circulations through the
heart, are formed. Faulty development of these structures can ultimately result in an inadequate
oxygen supply to tissues throughout the body which in newborn babies can lead to “infant
methemoglobinemia” better known as “blue baby syndrome”. In this project we continue our
investigations into the role of the second heart field (SHF) in the pathogenesis of congenital heart
disease. Specifically, we follow up on earlier published results and present new preliminary data
on the role of SOX9 in the SHF and its importance in the regulation of septation. Based on data
obtained during the last project period, we have designed three specific aims. In the first aim we
will focus on the role of SOX9 and other SOX family members in outflow tract septation, while for
the second aim we have designed experiments in which we will investigate the role of a new
candidate gene, proenkephalin (PENK), in outflow tract development. Finally, in our third aim, we
will, using a mouse model for Down syndrome, in which septation defects are frequently
encountered, test hypotheses about the mechanisms that lead to defects in this model and might
be involved in the etiology of defects in patients with Down Syndrome.

Public health relevance
Around one in every hundred babies is born with a congenital heart abnormality. In our research program we are studying the role of the second heart field in the pathogenesis of congenital heart disease. In this project we specifically focus on the role of SOX family members in outflow and ventricular septal defects.